The Role of IL-17 in Monocyte Migration

DESCRIPTION (provided by applicant): Project Summary It has been shown that interleukin (IL)-17 is important in the pathogenesis of animal models of Rheumatoid Arthritis (RA). However, the mechanism by which IL-17 promotes disease is incompletely understood. The TH- 17 cell, a new lineage of CD4+ T cells distinct from TH1 and TH2 is characterized by the production of IL-17. We identified increased numbers of TH-17 cells in RA synovial fluid (SF) compared to normal peripheral blood (PB). Adenovirally transferred IL-17 induced in vivo monocyte recruitment into the peritoneal cavity. IL-17, in the absence of other mediators, was chemotactic for monocytes at the concentrations detected in the RA SF. IL-17-induced monocyte migration was abrogated by neutralizing IL-17 receptor (R). We also demonstrated that IL-17 immunodepletion significantly reduced monocyte chemotaxis induced by RA SF compared to sham immunodepletion. The indirect effects of IL-17 on monocyte chemotaxis were also examined. RA synovial tissue (ST) fibroblasts and in vitro differentiated macrophages (IVD M$s) activated by IL-17 produced both MCP-1 and CCL20 while CXCL16 was only induced in M$s. Based on our preliminary data we hypothesize that IL-17 can induce monocyte transendothelial migration into the RA ST directly by altering integrin conformation on monocytes and thereby increasing their binding affinity to their cognate ligands on endothelium. Further, we hypothesize that IL-17 mediates monocyte recruitment into the synovium by inducing MCP-1 production by endothelial cells. The goal of this proposal is to examine whether IL-17-induced monocyte migration into the RA ST is through direct effects of IL-17 on monocytes or through the indirect effects of IL-17 mediated by chemokines and/or integrins produced by endothelial cells or perhaps both. The specific aims of this proposal are 1: a. Determine whether IL-17 promotes monocyte recruitment into RA ST engrafted in the severe combined immune deficiency (SCID) mice;b. Investigating whether IL-17R blockade on monocytes prevents their homing to engrafted RA ST in SCID mice in response to IL-17;2: a. Examine whether IL-17 can induce monocyte chemoattractant chemokines from the endothelial cells;b. Investigate whether IL-17 induces adhesion molecule activation (LFA1, VLA4) and expression (LFA1, VLA4) on monocytes, and endothelial cells (ICAM1 and VCAM1) or both;c. Investigate whether IL-17-induced monocyte transendothelial migration in laminar flow depends on its effect on adhesion molecules expressed on monocytes, endothelial cells or both. Successful completion of the proposed research will elucidate the mechanism by which IL-17 mediates monocyte recruitment into the RA ST. Those factors that regulate IL-17- induced monocyte migration may be potential therapeutic targets in RA. PUBLIC HEALTH RELEVANCE: Project Narrative. In rheumatoid arthritis (RA), migration of a type of immune cells called monocytes into the joint contributes to inflammation. In this proposal we demonstrate novel data showing that a pro-inflammatory cell signaling protein called IL-17 is important in the migration of monocytes, and that this effect occurs at the concentrations of IL-17 present in RA joint fluid. Successful completion of the proposed research will elucidate the mechanism by which IL-17 mediates monocyte migration in RA joint tissue. Those factors that regulate IL- 17-induced monocyte migration may be potential therapeutic targets in RA.

Public health relevance
Project Narrative. In rheumatoid arthritis (RA), migration of a type of immune cells called monocytes into the joint contributes to inflammation. In this proposal we demonstrate novel data showing that a pro-inflammatory cell signaling protein called IL-17 is important in the migration of monocytes, and that this effect occurs at the concentrations of IL-17 present in RA joint fluid. Successful completion of the proposed research will elucidate the mechanism by which IL-17 mediates monocyte migration in RA joint tissue. Those factors that regulate IL- 17-induced monocyte migration may be potential therapeutic targets in RA.